Project 2: Investigating the role of PAH exposures associated with superfund site proximity in preterm birth etiology through placental transcriptomics and metagenomics

Project 2 Summary
The burden of perinatal morbidity and mortality related to preterm birth (PTB) is astounding. Studies show that
environmental exposures contribute to an increased susceptibility to PTB. Identification of the causative etiology
of PTB is essential to improving global maternal and child health. During the prior funding period we have worked
to investigate the mechanistic role underpinning the increased risk of PTB with exposures to polycyclic aromatic
hydrocarbons (PAHs) during pregnancy. We have reported that proximity to Superfund sites in Harris County is
associated with increased levels of placental PAHs and increased preterm delivery. In this proposal we continue
to delve into the placental alterations which occur by virtue of PAH exposure and lead to preterm delivery. Our
central hypothesis is that exposure to PAHs and other environmental chemicals at Superfund sites will alter
the placental epigenome and disrupt functional gene expression. In order to investigate this we have proposed
three specific aims which leverage our research support cores as well as our data management and analysis
core. In Aim 1 we will utilize cutting edge methodologies to fully characterize epigenetic and transcriptomic
changes in placenta cells with PAH treatment. We will utilize RNA-seq, bisulfite-seq, RPPA and ATAC-seq to
fully profile these molecular changes in trophoblasts. With input from our DMAC team, we will integrate these
datasets using machine learning approaches in order to predict which epigenetic changes are associated with
changes in specific gene expression networks that could lead to preterm delivery. In Aim 2 we propose a
prospective study design where we will recruit subjects at delivery and collect placenta, maternal urine, maternal
serum, cord serum and colostrum (ie breastmilk). With support from the RSC we will measure levels of 16 PAHs
in these samples. We will utilize geostatistical modeling to integrate exposure data, residential address
information and maternal and neonatal outcomes data to reveal associations between proximity to Superfund
sites, exposures and maternal and neonatal outcomes. We will investigate epigenetic changes in the placenta
using RPPA. Of note, the subjects recruited as part of Project 2 will be followed for six months to determine
neonatal outcomes as part of Project 3. In Project 3, longitudinal breastmilk samples will be collected and PAHs
measured to determine exposures in neonatal life. In our third and final aim we will utilize unbiased LC-MS/MS
and GC-MS/MS approaches in order to investigate which environmental contaminants from Superfund sites are
associated with preterm delivery and which metabolic pathways in placenta are disrupted with these exposures.
Exposure data will also be modeled using geostatistical methodologies in order to determine how exposures
associate with proximity to Superfund sites.

Public health relevance
Project 2 Narrative Preterm birth remains as a major cause of morbidity and mortality in the United States, and the rates in Harris County are higher than the national average at approximately 12%. The research outlined in this proposal aims to continue our molecular studies of the placenta to understand how environmental exposures in pregnancy can contribute to preterm delivery. We will focus our investigation on polycyclic aromatic hydrocarbons, which are found in multiple Superfund sites in Harris County, and expand our investigation into other Superfund- related environmental toxins to comprehensively assess exposure levels, proximity to Superfund sites and risk of preterm birth.